Uncovering the role of BND2 cells in autoimmunity

Project Summary/Abstract
Type 1 diabetes (T1D) is an autoimmune disorder characterized by destruction of the pancreatic beta
cells, leading to decreased production of insulin and hyperglycemia. Although T cells are the primary effectors
of beta cell destruction in T1D, autoreactive B cells are also essential to the pathogenesis of T1D. Recent
evidence suggests a more important role for B cells in individuals who develop T1D at a younger age and
demonstrate rapid progression. However, little is known regarding the specificity, phenotype, and function of B
cells in young-onset T1D. Previously we performed a cross-sectional analysis comparing insulin-reactive to
tetanus-reactive B cells in the blood of newly-diagnosed T1D and controls using mass cytometry. Unsupervised
clustering revealed the existence of a highly activated B cell subset, we term BND2, that falls within the previously
defined anergic BND subset. We found a specific increase in the frequency of insulin-reactive BND2 cells in the
blood of young-onset T1D donors, which was further enriched in the pancreatic lymph nodes of T1D donors. The
frequency of insulin-binding BND2 cells correlated with anti-insulin autoantibody level and phenotypically BND2
cells appear to be capable of potent presentation of autoantigen to T cells. These findings suggest that activation
of insulin-reactive anergic B cells likely plays a role in the rapid progression of young-onset T1D. In this proposal
we seek to elucidate the mechanism by which these autoreactive B cells become activated and break anergy
(aim 1), determine their fate and function, i.e. whether they are, indeed, capable of acting as potent antigen-
presenting cells to T cells (aim 2), and determine whether they serve as a biomarker for development of T1D
(aim 3). The potential impact of these studies lies in understanding the role of insulin-binding BND2 cells in the
rapid progression of disease, which will inform our understanding of the aggressiveness of early-onset T1D and
increase the precision of future age appropriate therapeutics.

Public health relevance
Project Narrative Recent studies suggest a more pathogenic role for B lymphocytes in type 1 diabetes (T1D) subjects diagnosed at an early age compared to older-onset subjects. Recently we identified a specific increase in an activated insulin-binding B cell subset, termed BND2, in young-onset T1D subjects compared to older-onset T1D subjects. In this application we propose to further analyze the insulin-binding BND2 subset to determine how these cells might escape normal tolerance mechanisms to become activated, what their cellular fate and pathogenic potential is, and whether these cells could serve as a biomarker for development of T1D. Results from these studies would inform our understanding of the pathogenesis and rapid progression seen in young T1D patients and aid in future age-appropriate therapeutic targets to treat the disease.